Proximity epigenomics for context-specific analysis of complex chromatin features

Project Summary
Chromatin context defines all DNA transactions, from gene regulation to genome maintenance. Changes in
chromatin composition are hallmarks of cancer cells that contribute to malignant transformation and have been
studied extensively using a wide range of Next Generation Sequencing (NGS) approaches. However,
conventional genome-wide mapping efforts are limited to the detection of individual targets of interest, impeding
the study of their often diverse biological roles. Multi-subunit chromatin-regulatory complexes as well as protein
interactions with histones or noncanonical nucleic acid structures are largely defined through correlative analyses
of separate mapping efforts, which are unable to determine physical interaction, proximity on the same DNA
fragment or even presence in the same cell. These limitations underline an urgent need for improved, context-
dependent chromatin mapping and characterization efforts. In this application, we will establish a versatile and
broadly applicable technique that allows for the genome-scale analysis of two-component interactions on
chromatin. The proposal builds on our extensive experience in the study of genome-wide chromatin responses
to DNA damage, as well as the expertise of co-Investigator Dr. Michael Seidman in the analysis and visualization
of close-proximity molecular interactions in the context of DNA replication stress. Aim 1 will combine this
complementary expertise to develop Proximity-based Chromatin Immunoprecipitation (ProxiChIP), a tool to
characterize functional subsets of a given chromatin feature based on its interacting partners, shifting the current
ChIP paradigm towards combinatorial feature mapping. Using well-characterized, interacting chromatin binding
proteins as a proof of principle, we will convert a method currently restricted to the imaging-based detection of
protein interactions (proximity ligation assay, PLA) to a broadly applicable biochemistry tool suitable for
immunoprecipitation and a diverse set of downstream applications including NGS. In Aim 2, we will apply this
methodology to advance the epigenomic characterization of pathological RNA:DNA hybrids, a complex and
poorly understood feature of many cancer genomes thought to contribute to DNA replication stress, cancer
genome instability and therapy response. RNA:DNA hybrids have been mapped genome-wide using DNA:RNA
immunoprecipitation (DRIP) and related methods. However, existing approaches fail to distinguish between
physiological and pathological RNA:DNA hybrid subsets. ProxiChIP-based mapping of RNA:DNA hybrids in the
context of replication stress is expected to define the genomic features that underly pathological R loop formation,
which presents an essential step towards understanding their impact on genome integrity and malignant
transformation.

Public health relevance
Project Narrative Chromatin context is a critical determinant of all DNA transactions that is frequently perturbed in cancer cells. Genome-scale approaches to study chromatin are largely based on the detection of a single protein or molecular feature, resulting in one-dimensional data sets that fail to uncover the functional diversity of the target protein. We will establish a versatile and broadly applicable technique for the genome-wide mapping of complex chromatin features and will apply this method to advance the epigenomic characterization of pathological RNA:DNA hybrids, a poorly understood hallmark of many cancer genomes.